Administrative Core

The Administrative Core will coordinate the activities of the Projects and Animal Core. It will be responsible for encouraging the exploration of new research directions and for arranging consultations with the Internal and External Advisory Committees. It will be responsible for preparing scientific progress reports and renewal applications. It will organize the monthly meetings of the Projects at which research progress is presented. It will be responsible for budget allocation and for monitoring expenses. It will allocate travel funds. Two of the projects of the PPG are located offsite, in Chicago and in Madrid, Spain. Thus, important functions of the Administrative Core will be to facilitate discussions between the Projects by arranging videoconferences between the lowa, Loyola and Madrid projects and to coordinate two meetings per year at the University of lowa of all of the Project Directors. In summary, the Administrative Core will have a critical role in making sure that the PPG is efficiently organized and is productive as possible.

Public health relevance
This Program Project Grant is concerned with understanding the pathogenesis of SARS and in developing new vaccines that would be useful if SARS were to recur. The Administrative Core will have an important role in guaranteeing success of the project and providing administrative support so that members of the projects can concentrate on their research.